NCI National Clinical Trials Network - Lead Academic Participant Sites

Summary/Abstract: This grant will provide infrastructure support to the University of Colorado Consortium
Cancer Center and its clinical care partner UCHealth to continue to support the specific aims of the grant:
1. To provide leadership to the NCTN program and lead and participate in scientifically important and
clinically relevant NCTN clinical trials.
2. To make these trials available to the greatest proportion of the cancer population of Colorado and
Wyoming.
3. To rapidly activate, accrue, caringly provide patient coordination, and accurately report research related
data in a timely way to the NCTN components responsible for conducting these trials.
4. To foster and develop young investigators in the NCTN process.
Specific support is requested for the administrative, regulatory, clinical coordination, and data management
needs to conduct clinical trials of the NCTN safely and efficiently on behalf of the cancer patients in Colorado
and our wider catchment area. In addition, we will support enhanced monitoring and auditing to ensure patient
safety and proper conduct of the trials at all our sites of clinical care. Quality assessment and improvement are
a central feature of our NCTN program. We take seriously the mandate to participate in the development of
new concepts, the contribution of our laboratory scientists in these translational projects, and the fostering of
new junior investigators to further the clinical impact of therapeutic trials in the NCTN. Dialog and
communication are key. Within our institution, we have created a superb forum for our investigators across the
entire system (the LAPS Executive Committee) that represents all modalities and disease-oriented groups to
prioritize and commit to new trials, to monitor accrual and any other issues related to the conduct of these trials
across our system. We support travel for investigators, staff, and scientists to participate in the NCTN meetings
and committees. A new initiative will be supported with this grant – specifically to emphasize survivorship and
prevention with outreach to the underserved and rural populations. To this end, we have created a new team
within the Cancer Center's Clinical Trials Office to manage and recruit to these trials.

Public health relevance
Project Narrative The University of Colorado Cancer Center (UCCC) has provided significant leadership in the national cooperative groups since its inception. Since 2014, we became an NCI LAPS institution and have led with translational science and accrual and are full members of all 4 adult cooperative groups. Our sites of care include the UCHealth system which provides care to patients throughout Colorado and Wyoming using our integrated electronic medical records, clinical management trial system, regulatory and fiscal management of clinical trials.